Eastern Africa Network for Bioinformatics Training - (EANBiT)

EASTERN AFRICA NETWORK FOR BIOINFORMATICS TRAINING (EANBIT)
PROGRAM SUMMARY
Developing a critical core of research leaders requires a large starting pool of high-quality trainees
at the early stage of the training pipeline and support to enhance their progression. As such
Masters training, as the first stage of specialized research training, is a key determinant of the
quality of PhD students in the region. Unfortunately, many universities in eastern Africa do not
offer bioinformatics training at Master level and those that do often lack sufficient teaching
faculty and active research environments where the students can be exposed to high quality data
and emerging bioinformatics tools and approaches. Consequently, universities and research
institutions in the region struggle to recruit good quality bioinformatics research assistants and
PhD students.
The long-term goal of EANBiT is to develop bioinformatics research leaders. To achieve this, the
initial focus over the period of this grant period is to enhance bioinformatics training at Masters
level in the eastern African region to increase the number and quality of the pool of potential PhD
students.
OBJECTIVES
Our core objective is to measurably strengthen the application of bioinformatics in biomedical
research, through individual training, research mentorship and enhancing institutional capacity
in East and Central Africa.
Specific objectives
1. To develop a collaborative platform for promoting and strengthening bioinformatics training
and career development in universities and research institutes in eastern Africa.
2. Develop a harmonized bioinformatics curriculum at Masters level and support its adoption in
partner universities.
3. Generate a cohort of highly trained bioinformatics Masters graduates who can lead analysis of
data generated by H3Africa and other projects.
EXPECTED OUTCOMES AND PUBLIC HEALTH IMPACT:
We expect to progressively develop highly qualified bioinformaticians with the knowledge and
skills to contribute analysis of genomic, genetic and environmental data that are relevant to health
in eastern Africa, and to have equitable collaborations with peers in Africa and elsewhere. We
plan to train 12 participants each year at the level of Masters. The EANBiT hub is at the
International Centre of Insect Physiology and Ecology, in collaboration with Pwani University
(Kenya), Makerere University (Uganda), Uganda Virus Research Institute, KEMRI Wellcome
Trust Research Program (Kenya), ILRI-BeCA Hub (Kenya), and Muhimbili University of Health
and Allied Sciences (MUHAS) in Tanzania.
Our expectation is that graduates from this program will lead research, and take part in analysis
of complex datasets, and train the next generation of bioinformaticians.

Public health relevance
EASTERN AFRICA NETWORK FOR BIOINFORMATICS TRAINING (EANBIT) EXTENSION REQUEST SUPPLEMENT 1.0 Background The Eastern Africa Network of Bioinformatics training (EANBiT) project was established with an aim to measurably strengthen the application of bioinformatics in biomedical research, through individual training, research mentorship and enhancing institutional capacity. This network currently has a geographic focus in three East African countries: Kenya, Uganda and Tanzania, with seven (7) collaborating institutions. The program has in the last five years delivered the following outputs. 1) The establishment of a harmonized MSc. Bioinformatics curriculum in two Universities in East Africa (Pwani and Makerere), the latter in collaboration with the BRECA project (https://breca.mak.ac.ug). A third program is planned for September/October 2022 at Muhimbili University of Health and Allied Sciences (MUHAS) in Tanzania. 2) Two cohorts of MSc Fellows (total 22) have graduated from Pwani and Makerere with support from EANBiT. 3) All graduates from the first two cohorts have transitioned to either PhD positions of jobs as computational biologists and data scientists. 4) Our first cohort of students established what is now a very active bioinformatics community known as the Bioinformatics Hub of Kenya (@BioinfoHub_KE), which has more than 1500 followers. The leadership of this group that delivers training and mentorship opportunities has a core of EANBiT graduates. A total of 44 MSc. fellows have been recruited under the EANBiT project in four different cohorts. The third cohort of students are in the final stages of their MSc study, while the fourth and last cohort in this face will begin their project year in August 2022. 2.0 Work proposed for supplemental funding This supplemental request is for an additional 12 months to ensure completion of studies for the cohort recruited for the September 2021 term at the beginning of their two-year program that is due to end in July 2023. This supplemental funding request will ensure that ongoing trainees finalize their research project work and get an opportunity to participate in other capacity building activities, including scientific conferences and workshops, a planned students symposiums, and seminars. This completion will contribute to the objective of generating a substantial cohort of highly trained bioinformatics master’s graduates, and strengthening bioinformatics training and career opportunities. Although no fellowships will be awarded through EANBiT to the new MSc. Bioinformatics program at MUHAS, the fellows will be supported to participate in any group/residential training events and symposia. Completion of these activities will ensure that the project delivers fully on objectives outlined in the attached project summary, Annex 01. 3.0 Trainees progress Report and Training plan The supplemental request for the extension period will support the twelve (12) EANBiT Fellows in the fourth cohort; all are registered at Pwani University, Kenya. The trainees have finalized their taught semesters (course work sessions) and are currently undertaking a residential skills strengthening course that runs through July 2022. Thereafter they will begin their second year, which will see them undertake a research project with a thesis as the main output. Many of the Fellows will also submit manuscripts for publication in suitable peer-reviewed journals. They will be hosted at EANBiT and partner institutions. The residential training includes leadership and career development sessions, a Responsible Conduct of Research training, and bioinformatics skills strengthening and mini projects. A detailed training plan is provided in the Table below: TIMELINE ACTIVITY September 2022 Onboarding of Cohort 04 fellows at the institutions hosting their research projects November 2022 Completion of procedural registration of research projects and supervisors at Pwani University November 2022 - June 2023 Research project, data analysis and completion of thesis. July 2023 EANBiT’s student symposium July – August 2023 Thesis examination and final submission. 4.0 Budgets The estimated carryover amount is USD 120,000.00 (after August 2022) while the budget for the extension period is USD 190,174.93. An additional USD 50,000.00 is required to facilitate progression of the final cohort of MSc fellows, and complete the program as planned. USD USD 119,800.00 is budgeted for tuition, stipends, residential training workshop and a student symposium event. Funds for the final independent Scientific Advisory Board (iSAB) have also been budgeted to cater for travel and accommodation of iSAB members. The final iSAB meeting will be held together with the students’ symposium event to allow for mentorship sessions during the visit. The request for a supplement of USD 50,000.00 will cover secretariat support for the fellowship program ($12,296.50), medical insurance for MSc Fellows ($9,600.00), additional stipends for the 12 MSc Fellows ($14,400.00), travel costs for the final students symposium ($10,000.00), and Finance and Administration costs of $3,703.72.